Examining Interactions Between Opportunities and Propensities for Learning Math in Homes and Classrooms in Early Elementary Grades

PROJECT SUMMARY/ABSTRACT
Math achievement is one of the strongest predictors of college and career attainment, lifetime earnings,
and health outcomes. However, much of what comprises later math achievement is decided by the time
children enter school. Thus, it is essential to better understand environmental and cognitive determinants of
early math skills to close stubborn math achievement gaps. One way to consider these varied determinants is
within the Opportunity-Propensity (O-P) model. This model suggests characteristics can be organized into
three factors predicting achievement: antecedents represent distal variables which influence the context into
which the child is born (e.g., socioeconomic status); opportunities represent features of learning environments
(e.g., educational and extracurricular activities); and propensities represent proximal processes that facilitate
learning (e.g., executive function). This project aims to better understand ways in which opportunities and
propensities independently and interactively contribute to the development of early elementary math skills.
Individual differences in children's exposure to math language predict children's math skills. Prior studies
have described relations between math language input and math skills in homes and classrooms separately,
but little research has explored unique and/or complementary influences of these inputs. Furthermore, some
children have a greater propensity to learn from opportunities than do others and this might in part be
explained by variations in executive function (EF), skills recruited for goal-directed cognitions and behaviors.
Previous research has demonstrated robust relations between EF and math and suggests that EF might serve
as a compensatory mechanism for children who enter school with low levels of math skills. Further research is
needed to test whether EF interacts with math language to predict math skills.
The O-P model provides a useful framework for understanding the development of skills and a basis for
developing interventions. Antecedents are difficult to intervene upon and often require systemic policy change,
whereas propensities might be more easily affected at the child level. As observational data have suggested
propensities fully mediate relations between both antecedent and opportunity factors and achievement,
propensity factors might be an ideal target for intervention. As such, this investigation seeks to understand
whether modifying propensities affects achievement and/or relations between opportunities and achievement.
The primary goals of this research are to (1) examine relations between learning opportunities indexed by
math language and child skills; (2) test the role of EF in relations between math language and math skills; and
(3) train child propensities to elucidate mechanisms that lead to improvements in math. Findings will have
implications for intervention and learning science, policy, and practice. The proposed research is part of a
broader post-doctoral training program whose goal is to prepare the applicant for a career as an independent
researcher focused on the development of early math skills as faculty at a top-tier research university.

Public health relevance
PROJECT NARRATIVE Math achievement is one of the strongest predictors of college and career attainment, lifetime earnings, and health outcomes; however, much of what comprises later math achievement is decided by the time children enter school. It is critical to better understand environmental and cognitive determinants of early math skills to close stubborn math achievement gaps. The proposed research program seeks to (1) explore relations between math-relevant language input and child skills; (2) test the role of executive function in relations between math-relevant language and child math skills; and (3) examine data from a study that trains domain- general and domain-specific math skills in order to elucidate mechanisms that lead to improvements in math.